Exploring the Impact of Illness Identity on Intersectional Stigma Through the Care Continuum

PROJECT SUMMARY
Tuberculosis (TB) and HIV stigma causes significant morbidity and mortality in South Africa. Despite curative
treatments for TB and antiretroviral therapies that suppress HIV viral load, both diseases continue to spread in
low- and middle-income countries. Stigma is a significant barrier to care engagement and treatment
adherence for HIV and TB. Intersectional stigma theory acknowledges the infinite combination of identities that
contribute to stigma and social erasure. However, this wholistic approach of social constructs is not easily
translated into measurement science. The applicant's proposed study, Exploring the Impact of Illness Identity
on Intersectional Stigma Through the Care Continuum, will address this gap. The purpose of this project is to
explore intersectional TB/HIV stigma through the care continuum to determine whether HIV viral suppression,
and TB culture/smear conversion represent changes in illness identity that mitigate stigma. Aim 1 will quantify
TB/HIV stigma using the Van Rie Patient Perspectives on TB/HIV Scales and use repeated measures ANOVA
to evaluate significance in changes of stigma over time. In Aim 2, the applicant will use in-depth qualitative
interviews to explore nuance and variation of intersectional stigma throughout the care continuum as
experienced by people living with TB and HIV in South Africa that may not be captured within the Van Rie
Scales. From the qualitative interviews, the applicant will develop and pilot four to five additional instrument
items to address the overlap in TB/HIV stigma that is not captured within the parallel items of the Van Rie
Scales. Finally, in aim 3, the applicant will interpret and integrate the qualitative and quantitative data to create
a deeper understanding of intersectional TB/HIV stigma in South Africa and to assess its impact on treatment
engagement across the care continuum. The applicant will use data from this proposal to improve the
accuracy of stigma measurement in South Africa. This study will lay the foundation for future career in global
stigma analysis and intervention work. It is therefore, an important first step in an exciting program of research
to reduce stigma and improve TB and HIV treatment outcomes for global populations.

Public health relevance
PROJECT NARRATIVE Stigma is a significant barrier to accepting and engaging in TB and HIV care; but there is little research evaluating if and how level of stigma changes throughout infectious disease treatment. The purpose of this project is to explore intersectional stigma through the TB/HIV care continuum to determine whether treatment engagement, HIV viral suppression, or TB cure mitigate stigma. This proposal will help to determine if, and when, stigma is likely to increase, and to help ascertain when the overlap of TB and HIV stigma is most salient in order to develop tools with clinical value and appropriately tailor intervention strategies.